A multidimensional approach to studying the impact of caregiving on health among dementia caregivers

Family caregiving is both essential and highly respected in contemporary societies. In the U.S., very few affordable alternatives to family caregiving are available for the care of individuals living with Alzheimer’s disease and related dementia (ADRD). Protecting and promoting the health and well-being of family caregivers is crucial. The daily care and supervision of a family member living with ADRD have been associated with threats to the health and well-being of family caregivers, who often experience an overall decrease in quality of life indicators. Although more is known about the relationship of caregiving and psychosocial distress, such as depression, far less is known of the relationship between ADRD caregiving and physical health indicators and the relationship between changes in these indicators and health outcomes. Furthermore, not all caregivers have poor health effects, but we have little understanding of the profile of various health responses to caregiving. In particular, spouses of persons with ADRD are challenged by a chronic diseases and, for some, poor health outcomes; yet the health effects of caregiving vary across caregivers with some having few physical health issues and others having multiple physical health issues. A multidimensional approach inclusive of health indicators and outcomes from multiple data sources is required to fill this gap in the study of the physical health of family caregivers. The purpose of the proposed project is to characterize the health risks of ADRD spousal caregivers using self-reports of physical health and functioning, clinical health indicators, and health care utilization data represented in electronic health records (EHR). The research team will recruit spousal caregivers of individuals with ADRD, extract various health indicators from EHRs, including health care utilization, and use survey methods with a cross-sectional design to collect self-reported health and functioning as well as health behaviors. More specifically, using latent class analysis, this proposal addresses three specific aims: 1) characterize health risk profiles through a combination of objective and subjective assessments of health status among spousal caregivers; 2) Identify the degree of intensity of caregiving experience and patterns of health care utilization among spousal caregivers for the distinct health risk profiles determined in Aim 1; and 3) assess health promotion behaviors that serve as protective factors in the relationship between stressful caregiving experiences and health care utilization among subgroups of caregivers. Consistent with the purpose of the R21 funding mechanism, the expected outcomes of the project will provide a method for monitoring spousal caregiver health indicators. The study will inform the development of tailored interventions to address health risks among spousal ADRD caregivers. Findings from the study will provide the need for, and design of caregiver health risk identification algorithms that can be integrated into EHRs. The long-term goal of the proposed research is to improve recognition of caregivers’ health risks and to develop tailored interventions that reduce caregivers’ physical health burdens associated with providing continuous care for their spouses with ADRD in health care systems.

Public health relevance
Caregiving can have a negative effect on the health of caregivers; however, much variation exists in caregivers’ health and health outcomes. The purpose of this study is to identify profiles of health risks among spousal caregivers of persons with Alzheimer’s disease and related dementias (ADRD), assess health care utilization for each of the profiles, and determine the role of health promotion behaviors in these profiles. The findings from the study will increase patient care support by improving recognition of caregivers’ health risks and enhance the tailoring of health care services for spouses of persons with ADRD in health care systems.